DNA-damage-induced transcription errors provide a constant stream of amyloid and prion-like proteins in human cells

ABSTRACT
Aging is characterized by the accumulation of amyloid and prion-like proteins. However, the molecular
mechanisms by which these proteins arise remain unclear. The overarching hypothesis of this proposal is that
the amyloid and prion-like proteins that accumulate in aging cells are generated by mistakes that occur during
transcription. To test this hypothesis, we will screen a database of 260,000 transcription errors identified in
human stem cells, brain organoids and fully differentiated neurons for candidates that are likely to create amyloid
peptides. We will then use a variety of cellular, biochemical and biophysical tools, including cryo-EM, TEM and
fluorescent imaging to test the amyloid behavior of these proteins. Our preliminary data indicates that these
experiments will create a powerful proof of principle of our hypothesis. Next, we will test how these transcription
errors are generated. Several studies suggest that DNA damage plays an important role in this process,
indicating that age-related DNA damage could drive the accumulation of amyloid and prion-like proteins. To test
this hypothesis, we will use single-cell-sequencing coupled to a new, custom-made bio-informatic pipeline to
determine if human neurons exposed to DNA damage display error prone transcription, and if so, how many
mutant proteins are generated as a result. Our preliminary data indicates that O6-methyl guanine lesions, a
common form of DNA damage in the brain, creates vast amounts of mutant proteins in single cells, strongly
supporting our hypothesis. Next, we will determine whether these errors are sufficient to induce protein
aggregation in human neurons using a plasmid-based system that contains a carefully placed O6-methyl guanine
lesion. Finally, we will test if O6-methyl guanine -induced errors can affect the pathology of Alzheimer’s disease
by removing the DNA repair gene MGMT in the neurons of a mouse model that carries a humanized version of
the APP protein. MGMT repairs O6-methyl guanine lesions, which will allow these lesions to accumulate over
time, increasing transcriptional mutagenesis. Moreover, it was recently found that MGMT is down-regulated in
female patients with non-familial cases of AD, so that this experiment closely mimics the conditions of human
patients. Accordingly, we think that in addition to testing our hypothesis, these experiments could also lead to
the first mouse model that fully mimics late onset, non-familial cases of AD. The most exciting aspect of our work
though, is the challenge we pose to the DNA-centric way of thinking in modern medicine. Our work shows that
in some cases, the mutations that give rise to disease do not have to occur in the genome, they can also occur
in the transcriptome. In doing so, our research could establish a new paradigm in modern medicine and open up
a new field of aging research to widespread experimentation.

Public health relevance
PROJECT NARRATIVE When our cells activate a gene, they make a disposable copy of it that can be used for various biological purposes. We will investigate whether mistakes are made when these copies are synthesized and determine how these mistakes affect human health. Ultimately, these experiments could provide new insight into the natural aging process and the origins of various human diseases, including Alzheimer’s disease, Parkinson’s disease and cancer.